CRCNS: The diffusional complexity of the brain's extracellular space

This proposal brings together two laboratories with complementary experimental and computational
expertise to determine the complexity of the extracellular space (ECS) in the brain at nanoscopic
resolution in live tissue and its effects on neuronal function. The Spanish laboratory has spearheaded the
development of super-resolution shadow imaging (SUSHI). The US team will use computer models to
study the consequences of using competing hypotheses of how the ECS complexity affects the diffusion
of neurotransmitters, which they will test experimentally. Neuronal structural complexity can cause a
breakdown of classical diffusion, resulting in anomalous diffusion. A molecule can experience anomalous
and normal diffusion at different temporal scales. Depending on which diffusional process dominates will
affect the spread and relative concentration of ECS diffusing signals, such as neurotransmitters. SUSHI
experiments will measure the structure of the ECS in live hippocampal organotypic and acute slices
focusing on perisynaptic excitatory and inhibitory areas of CA1 pyramidal neurons. The values of the ECS
volume fraction and the pore-size of the interstitial fluid (ISF) will be determined as a function of age,
which is known to affect the ECS structure. SUSHI will be used to measure diffusional properties of the
ECS at nanoscopic resolution over microscopic regions. These measurements will determine whether
diffusion is anomalous or normal and over which periods of time. Monte Carlo and differential equation
models and theory will examine the anatomical properties that cause anomalous or normal diffusion. The
models will be extended to predict the effects of ECS structure on biochemical signaling at different
spatio-temporal scales. The team will test the hypothesis that modifying the ECS volume directly affects
the relative strength of neurotransmitter signals. Experiments will use a combination of electrophysiology
with pharmacological and optogenetic manipulations to determine the effects of changes in ECS volume
on the relative strength of excitatory and inhibitory (tonic and phasic) synapses. The experimental
manipulations will mimic pathological conditions such as epilepsy and gliosis. The experiments will be the
basis to build biophysical detailed models of pyramidal hippocampal cells to determine how the excitability
of these cell changes as a function of ECS structure.

Public health relevance
Neurological diseases and stroke affect the extracellular space among neurons. Determining how changes in structure of this volume affect neuronal activity will allow a better understanding of how the brain functions in health and disease. Work performed in this project will provide essential information that could be of translational use in cases of neuroinflammation and trauma.